Ophthalmic Microscope with Intraoperative Optical Coherence Tomography

ABSTRACT The Medical College of Wisconsin prioritizes research as one of its missions and includes in its strategic plan “accelerating discovery with cutting-edge, evidence-based research.” With this support we request funds for the shared instrumentation of a Leica Microsystems Proveo 8 ophthalmic surgical microscope with intrasurgical EnFocus optical coherence tomography. The equipment would be used by eleven faculty from four departments from two institutions. We describe four major thematic programs and four additional minor projects that will be supported by eleven users, including five major and six minor users. Uses for the equipment includes ophthalmic, vascular, and oncologic, along with teaching applications. This instrument is requested to replace two outdated operating microscopes. The requested equipment would provide video documentation to increase rigor and transparency of research. It would also improve procedures to reduce and refine the use of animals in research projects. A compact footprint will decrease space requirements. This state-of-the-art instrument will help advance NIH-funded research and help future research applications in southeast Wisconsin.

Public health relevance
PROJECT NARRATIVE This shared instrument proposal requests funding for a Leica Microsystems Proveo 8 ophthalmic surgical microscope with intrasurgical EnFocus optical coherence tomography at the Medical College of Wisconsin. The equipment would be used by eleven faculty from four departments from two institutions in southeast Wisconsin to enhance collaborative and innovative research programs.